Stimulation mediated sensory enhancement of the urethral afferents

DESCRIPTION (provided by applicant): Urinary retention is a disease of the urinary tract that prevents hundreds of thousands of people from properly emptying the contents of their bladder. Urinary retention can be caused by many things such as natural aging, acute trauma (especially during surgical procedures), diabetes, multiple sclerosis and others. Despite the range of causes, a feature common to most cases of urinary retention is a reduced neural sensitivity for detecting fluid flow in the urethra. This reduction in sensitivity, in turn, limits the effectivenes of reflexes that naturally control bladder voiding. We hypothesize that enhancing urethral sensitivity will mitigate many of the symptoms associated with retention by allowing the reflexes to once again function properly. The work in this proposal will demonstrate that it is possible to enhance urethral sensitivity. To accomplish this enhancement we will use a process called stochastic resonance, where we inject sub-threshold levels of electrical noise (amounts small enough that they cannot be detected by the sensory neurons) directly into the urethra. This will be done in a rat model of the urinary tract. Stochastic resonance has been successful in other biological sensory systems and we hypothesize that these undetectable perturbations will lower the activation threshold of the urethral sensory neurons, effectively increasing their sensitivity o flow. We will demonstrate our findings by recording from the pudendal nerve, which carries sensory information from the urethra to the spinal cord. We will compare the pudendal nerve's response to fluid flow in the urethra both with and without the stimulation at a range of flowrates We can conclude that sensitivity was enhanced if more neural activity is observed in the presence of the stimulation than without it, and if slower flowrates can be detected with the stimulation it will also serve as evidence of enhanced sensitivity. Finally, a mathematical model of stochastic resonance in the lower urinary tract will be developed in tandem with the animal experiments. This model will allow us to simulate many different types of stimulation and flowrates to better guide the animal work. Using the model we can investigate a wide range of experiment parameters, many more than we could test using the biological system. We will use the model estimates of the optimal stimulation parameters and flowrates to give ourselves the best chance of success for enhancing urethral sensitivity.

Public health relevance
PUBLIC HEALTH RELEVANCE: Thousands of people are diagnosed with urinary retention (the inability to initiate or complete urination) each year in the United States, which can lead to numerous health complications such as urinary tract infection. We will demonstrate by using small amounts of electrical current it is possible to boost the sensitivity of neurons that monitor the urethra, thereby restoring function to the reflexes that control proper urination and alleviatig symptoms of urinary retention. __SpecificAimsTextDelimiter__ 2. Specific Aims Urinary retention is the inability to begin emptying or to empty completely the bladder and accompanies many types of neurological disorders which often lead to increased morbidity and diminished quality of life. A reduction in urethral afferent (sensory) activity accompanies urinary retention in a variety of cases. We hypothesize that enhancing the sensitivity of the urethra may mitigate many of the symptoms seen in urinary retention where the reflex pathways controlling voiding remain intact, such as some types of incomplete spinal cord injury, diabetes, cases of partial damage during surgery, and age related retention. The objective of this work is to demonstrate the feasibility of a new intervention for urinary retention: enhancing urethral afferent sensitivity by introducing very low levels of electrical noise in the urethra. The process, where small stochastic continuous perturbations result in enhanced neuronal sensitivity to stimulus, is called biological stochastic resonance (SR) and has been repeatedly shown to exist in myriad biological systems since the 1980s. We hypothesize that we can synthesize this naturally occurring phenomenon and apply it to the urethra, thereby boosting afferent response during urethral flow and enhancing the efficiency of bladder emptying. Enhancing urethral sensitivity via electrical stimulation will enable the further development of this technique as a basis for treatment of urinary retention. The proposed work involves a rat animal model of the urinary tract and a computational model of the urethral afferent neurons. Aim 1 is to quantify the change in sensitivity of urethral afferents generated by low levels of electrical stimulation in the rat urethra. It has been discovered that SR can heighten detection thresholds of cutaneous sensory neurons. However, it remains unknown if this phenomenon can be reproduced in the urethra. Therefore, the first objective is to determine whether injecting subthreshold levels of noise-like current into the urethra will enhance urethral afferent sensitivity to physiologically relevant stimulation (flow). We will determine sensitivity thresholds of urethral afferents by recording activity in the pudendal nerve in response to a range of physiological flow-rates in the presence and absence of the electrical stimulation. We will test the hypothesis that injected subthreshold current can increase the sensitivity of urethral afferents. We will also quantify afferent responses to different levels of urethral fluid flow and determine their detection thresholds. This will allow us to test afferent responses to a range of noise intensities applied during subthreshold flow-rates to obtain a signal to noise ratio profile for the afferents, and thereby determine the optimal noise levels for SR. Aim 2 is to develop a computational model of the effects of electrical stimulation on urethral afferents to guide the selection of stimulation parameters in Aim 1 to achieve maximal sensory enhancement. We will use the model to determine the electrical noise levels that are most likely to achieve high signal to noise ratio for SR. Additionally, the model will guide us designing a train of stochastic current pulses that can stand in for the continuous electrical noise that is typically used in SR studies because pulse trains are typically used for neural stimulation. We will modify a Hodgkin-Huxley type neuron model to include slowly gated sodium channels, which are thought to be the mechanism that is most likely responsible for frequency adaptation in rat mechanoreceptor neurons. Because neural frequency adaptation alters the coherence between a signal and the corresponding neural response it is necessary to include this feature in a computational model of stochastic resonance. The optimal noise distribution will vary based on the type of neuron and the frequency content of the periodic stimulus, and therefore we will examine a range of noise current distributions for mechanoreceptors of different frequency adaptation rates using a range of periodic stimuli as well as aperiodic stimuli. The main reason we will investigate the use of randomly presented subthreshold pulses as the electrical "noise", even though SR is typically achieved through the application of continuous random noise, is that electrical neural stimulation is mainly delivered as a train of short pulses in practice. Therefore, substituting a randomized pulse train with true continuous noise will facilitate the eventual translation of our findings.